ODA AFRPS PAR-25-003

Ohio’s Project Summary
The Ohio Department of Agriculture (ODA) will continue to develop and implement the Animal Food
Regulatory Program Standards. These standards will create a uniform and consistent inspection process
benefiting the firms regulated by our program. ODA is prepared to document and share information
with FDA during the time frame of this grant. Our program is also prepared to continue these standards
after the grant expires. ODA is applying for the AFRPS Development funding opportunity provided by
FON # PAR-25-003.

Public health relevance
Ohio’s Project Narrative The Ohio Department of Agriculture (ODA) implementation of FDA’s Animal Food Regulatory Program Standards will help improve our states efforts to protect Ohio’s and the U.S. animal food supply. The funding this grant offers will allow ODA to complete the objectives outlined in the statement of work.